Functional Dynamics of Neurotransmitter:Sodium Symporters (NSSs)

Neurotransmitter:sodium symporters (NSS), the target of therapeutic and illicit drugs, share a common structural
core, e.g., the LeuT fold, with secondary transporters that harness the energy from (electro)chemical ion and/or
substrate gradients to power concentrative substrate symport and/or antiport. This multidisciplinary proposal,
involving iterative functional, spectroscopic and computational methods, seeks to identify commonalities and
divergences in the modes of transport of archetypes of LeuT-fold transporters in the context of differences in the
regulatory role of ions on the driving mechanism and the conformational changes associated with substrate
binding and translocation with special emphasis on how psychoactive drugs modulate the activity of human
serotonin transporter (hSERT). By taking advantage of recent and preliminary findings and state-of-the-art
technologies established in the participating labs, the major goals of the research described in this grant proposal
are the identification of the conformational dynamics associated with the different modes of transport, the binding
sites and permeation pathways of substrates, ions, and drugs within the transporters, and how therapeutic and
illicit psychostimulants modulate the transport process in hSERT. We are particularly interested in testing our
central hypothesis that the mechanistic differences associated with discernable local structural changes and
dynamics are specific to the respective LeuT-fold families, culminating with the remarkable complexity of the
transport mechanism of hSERT, representative for mammalian NSSs, with the overall goal to close the gap in
our understanding of their role in health, disease, and pharmacotherapy. To reach this goal, our line of attack
follows three specific aims, 1) to map the conformational dynamics associated with concentrative substrate
transport by testing our hypothesis that functional specialization entails, in addition to common elements of
alternating access, divergent structural changes between transporter families using double electron-electron
resonance (DEER) spectroscopy to measure distance distributions between pairs of strategically selected
positions in representative LeuT-fold proteins, 2) to delineate the ion-dependent regulation of concentrative
substrate transport by interrogating our hypothesis that concentrative substrate transport is regulated by
transporter-specific discernable ion binding events using binding and flux studies in conjunction with DEER
experiments, and 3) to test the model that amphetamine-induced hSERT reverse transport entails an antiport
mode by testing the hypothesis that amphetamine-elicited serotonin efflux entails in part a switching of the
transport mode that is associated to unique conformational changes in the N-terminal region, whereas the
binding of cocaine, another psychoactive drug, inhibits serotonin transport by blunting the forward transport
mode-associated transitions. Thus, obtaining a holistic understanding of transport mechanism and implementing
a new paradigm for illuminating drug action and providing guidelines for improved therapy design are the long-
term goals of this proposal.

Public health relevance
Neurotransmitter:sodium symporters (NSS), the target of therapeutic and illicit drugs, share a common structural core, e.g., the LeuT fold, with secondary transporters that mediate concentrative substrate symport and/or antiport. By targeting archetypes of LeuT-fold proteins the goal of this grant proposal is to identify the binding sites and permeation pathways of substrates, ions, and drugs within the transporters and the elucidation of the conformational dynamics associated with the different modes of transport, with special emphasis on how psychoactive drugs modulate the activity of the human serotonin transporter (hSERT) at the molecular level. Building on powerful approaches established in the associated labs will allow implementing a new paradigm for illuminating drug action and providing guidelines for improved therapy design.